QUALITY OF LIFE AND AUTONOMIC FUNCTION IN YOUTH WITH IDDM

To establish normative age-related indices for autonomic, function, identify differences in quality of life and autonomic function and explore the biobehavioral linkage between autonomic function and quality of life in youth with IDDM.